Phase 2 Study of Deferiprone in the Treatment of NBIA

DESCRIPTION (provided by applicant): This is a clinical study to treat patients with a rare genetic movement disorder known as neurodegeneration with brain iron accumulation (NBIA). It is characterized by the progressive degeneration of the nervous system and iron accumulation in the brain, primarily the basal ganglia. There is no cure for NBIA, which primarily affects children. Iron chelator therapy has been proposed, but not systematically studied as a treatment because of the lack of an iron chelator that effectively crosses the blood-brain barrier. Deferiprone, an oral iron chelator, used internationally for the treatment of systemic iron overload, crosses the blood-brain barrier. Clinical reports suggest deferiprone at approximately 30 mg/kg/day has radiographic and clinical efficacy in symptomatic patients with excess brain iron but no systemic iron accumulation. The primary aim of this study is to establish the safety of deferiprone in NBIA, and demonstrate efficacy of deferiprone in diminishing dystonic behaviors. The proposed research study will be a blinded, placebo-controlled, randomized trial of drug versus placebo in a 2:1 ratio in 40 patients over a four year period. Patients eligible will be NBIA/PKAN mutation positive, over 8 years of age, who have failed therapy and have shown clinical progression without improvement over the last six months. An MRI protocol using R2 of the brain will measure changes in brain iron content. Outcome measures will include improvement in neurologic and functional assessments.

Public health relevance
PROJECT NARRATIVE Iron deposits in the brain have been found in many degenerative diseases like Parkinson's, Alzheimer's, and in the fatal childhood genetic syndrome known as Neurodegenerative with Brain Iron Accumulation (NBIA). Children with this disorder have progressive problems with speech, balance, walking and even eating. This proposal will study the safety and possible benefits of Deferiprone, a drug that removes iron from the brain, in children and adults with PKAN. The outcome of this trial may have scientific and therapeutic benefits to patients with many other neurodegenerative diseases. __SpecificAimsTextDelimiter__ 2.0 SPECIFIC AIMS This is a clinical study to treat patients with a rare genetic movement disorder known as Pantothenate Kinase-Associated Neurodegeneration (PKAN), which is a form of Neurodegeneration with Brain Iron Accumulation (NBIA). It is characterized by the progressive degeneration of the nervous system, and iron accumulation in the brain, primarily the basal ganglia. There is no cure for PKAN. This study will randomize 40 patients to receive deferiprone (3-hydroxy-1,2-dimethylpyridin-4-one) (DFP) or placebo in a 2:1 ratio (27 patients on DFP and 13 on placebo) for one year. Functional assessments, in particular of dystonic behavior, will be followed as well as changes in quantitative brain iron. The goal of this study is to establish the safety of DFP, an iron chelator drug, in PKAN and to demonstrate its efficacy in diminishing dystonia. The study will establish a multidisciplinary working relationship among specialists in hematology, neuro-radiology, physiatry, neurology, and genetics to address neurodegenerative diseases with excess iron. The potential impact of the proposed study is not limited to PKAN patients. The outcome of this trial may have scientific and therapeutic benefits to a host of neurodegenerative disorders with excess brain iron. This protocol design is based on the required guidelines of the FDA IND 104880. The success of DFP in individual cases treated under a compassionate use IND led to the following protocol for a clinical trial to evaluate the safety and potential efficacy in a larger group of patients with NBIA. The protocol was specifically developed under the direction of the FDA (Appendix A), including the Division of Medical Imaging and Hematology Products and Division of Neurology Products, as an alternative to many individual compassionate use requests. The protocol underwent several revisions based on FDA instructions including fixed dosing, randomized design, and outcome analysis. This study follows the required FDA IND-approved study protocol. PRIMARY AIM A: To develop safety and tolerability data of a 30 mg/kg/day dose of deferiprone in patients with PKAN. PKAN is characterized by accumulation of iron in the central nervous system (CNS) with progressive neurological deterioration characterized by dystonia, dysarthria and rigidity often progressing to death. DFP is an orally-available iron chelator that crosses the blood-brain barrier. Reports suggest DFP at approximately 30 mg/kg/day has radiographic and clinical efficacy in symptomatic patients with excess brain iron but no systemic iron accumulation. The results of this trial will add evidence for the safety of this dose of DFP in patients with normal systemic iron concentrations. PRIMARY AIM B: To demonstrate efficacy of deferiprone in diminishing dystonic behaviors in patients with NBIA. Dystonia is the most frequent early and ongoing manifestation of this disease. The Barry-Albright Dystonia (BAD) scale is a reliable rating scale and has been used to quantify baseline and changes in dystonia in patients with NBIA treated with deep brain stimulators. We propose to utilize the BAD to assess the efficacy of deferiprone in patients with PKAN. Secondary Aim 1: To assess changes in self care abilities, mobility, cognition and health related quality of life as a result of treatment with DFP utilizing the WeeFIM II (or FIM in adults), and SF-36v2" or PedsQL" scales at baseline, 6 months, and 1 year. The WeeFIM scale is a standardized instrument that assesses multiple parameters affected by PKAN. It has excellent rater reliability in other childhood disabilities. Similarly, the SF-36v2" and PedsQL" (for patients under age 18) are accepted standardized health related quality of life instruments. Secondary Aim 2: To assess changes in MRI iron content at baseline, 6 months and 1 year in a subset of subjects who do not have Deep Brain Stimulators. Patients with classical PKAN2+ mutations all show excess iron in the brain, particularly the medial globus pallidus. Iron deposition in the brain can be quantified. Preliminary data in Friedreich ataxia treated with DFP resulted in a significant decrease in the relaxation rate T2*/R2 brain MRI. A case report with an NBIA patient treated with DFP was similar. Both the magnitude and phase of gradient echo MRI data will be used to detect longitudinal changes in brain iron during therapy. Its correlation with functional assessment tools will be investigated.